Enhancing digital CBT-I to improve adherence and reduce disparities

PROJECT SUMMARY/ABSTRACT
Insomnia is a debilitating condition that escalates risk of a myriad of disorders, and affects up to one third of
adults. Although insomnia can be effectively treated with Cognitive Behavioral Therapy for Insomnia (CBT-I),
there is a shortage of specialty providers trained in CBT-I. Consequently, most patients with insomnia are
unable to receive CBT-I as the recommended first-line intervention for insomnia. To address this problem,
CBT-I can now be delivered digitally (dCBT-I) with strong efficacy; however, the real-world effectiveness of
dCBT-I is limited by poor engagement. Over 50% of patients do not complete the full course of dCBT-I, and
40% of those who persist in treatment do not adhere to critical components of dCBT-I. Moreover, treatment
completion and adherence are 2-3 times worse in those with low socioeconomic status. Our pilot data indicate
that the disparity in completion and adherence to dCBT-I is related to low health literacy, defined as the ability
to find, understand, and use information and services to inform health-related decisions. Health literacy is
especially critical for engagement with digital interventions that are self-guided, such as dCBT-I.
This proposal responds to an announcement focused on improving patient adherence to treatments. We
propose a large-scale intervention comparing enhanced dCBT-I to control dCBT-I in improving treatment
completion and adherence in a sample stratified by socioeconomic status. We also propose to test the effect of
enhanced dCBT-I on reducing socioeconomic disparities in treatment adherence and completion. An
innovative component of this trial is the use of non-specialist coaches as a scaffold for low health literacy, and
to enhance treatment motivation and self-efficacy. Furthermore, those who are at-risk for treatment non-
completion are shifted to telehealth coaching focused on one single critical behavioral component tailored for
ease of assimilation into the patient’s daily life. The adaptive component provides patients two different
treatment modalities to maximize engagement and both approaches leverage technology to increase
accessibility. Our long-term goal is to ensure equitable effectiveness of digital insomnia treatments. To that
end, our overall objective is to determine how adherence and completion in dCBT-I can be improved,
particularly in those with low SES as a health disparities population. Based on pilot data, our central hypothesis
is that, compared to control dCBT-I, enhanced dCBT-I will increase engagement by providing targeted support
for those who need it.

Public health relevance
PROJECT NARRATIVE Cognitive behavioral therapy for insomnia can now be delivered digitally (dCBT-I), enabling millions of individuals access to the recommended first-line therapy for insomnia; however, overall rates of treatment completion and adherence are less than 50%, with larger disparities in those with low socioeconomic status. The proposed project will test enhancing dCBT-I with telehealth coaching to reduce disparities and improve overall engagement to digital insomnia treatment.